Short-term research training at New England College of Optometry

Project Summary
We are requesting continued support for the short term research training program at the
New England College of Optometry (NECO), to run from 5/1/2020 through 4/30/2025.
Each year the program will support 8 eligible pre-doctoral students, mainly from NECO.
The program will introduce these future optometrists to laboratory-based research, with
the goal of encouraging future career choices as clinician-scientists or academic faculty.
During the program students will learn how to perform a rigorous research project,
through participation in their assigned laboratory and in weekly seminars on topics such
as the ethical conduct of science, critical literature review, and statistical analysis of
data. They will gain experience in oral presentations and scientific writing, and learn
how research results can be translated into clinical practice. Students will be exposed to
research on topics such as low vision, ocular aberrations, ROP, circadian rhythms of
eye growth, and effects of lighting on myopia. By the end of the program students
should have a clear understanding of what is involved in conducting rigorous research
and presenting results, both orally and in writing.
Applications are solicited from students at NECO and other colleges of optometry. The
applicants with the strongest academic records and recommendations are accepted into
the program. They have a wide range of research ability and experience, which we take
into account in assigning mentors. The mentor is responsible for guiding the student
through all stages of the program. Most of our mentors are established researchers,
with a few new junior faculty members added to the list, to be supervised by the
program director and co-director. Most of the participating faculty members have
funding from NIH or other external or internal sources.
If past performance is any indication, some of these new students will choose to pursue
a Master’s degree in addition to the OD, and a few will include research as part of their
career plans. Research-trained doctors can have a significant impact on patient care or
in the classroom when training future optometrists.

Public health relevance
Project Narrative The goals of the short term research training program at NECO are to introduce optometry students to all aspects of vision research and to provide opportunities for participation in rigorous research. We aim to train the students in strong experimental design and execution. Based on previous experience we know that some of these students will further their training by pursuing a Master’s degree in vision science in addition to the OD degree, and some will choose a career in academia or research.